Defining Relationships of Early Mediators and Moderators of Sleep (DREAMS)

PROJECT SUMMARY/ABSTRACT
Major causes of sleep deficiency affect around 40% of children at some point and 11% through adulthood.
Causes of pediatric sleep deficiency are defined by adverse dimensions of sleep health. If untreated, early
sleep deficiency can contribute to health, behavior, and learning disparities at kindergarten entry that may
persist into adulthood. Yet, early causes of sleep deficiency are grossly underdiagnosed in primary care, and
few receive evidence-based treatment. Evidence also suggests that sleep deficiency and downstream
outcomes are significantly worse for children with family risk factors such as low income, education, and parent
mental health. Because these risk factors are unjustly borne by children who are Black or living in poverty,
whose families have few resources to seek help outside of primary care, these sleep health disparities reflect a
critical early health inequity. Yet, limited research defines inequities in early childhood sleep health and missing
from this work is the examination of the effects of racism, housing instability, peak levels of screen media use,
and toxic stress on child sleep health. Our long-term goal is to design and test strategies and health policy to
prevent and remedy inequities in early sleep health. Our objective in this proposal is to empirically test the
sleep health socioecological framework to define how comprehensive multi-level socioecological factors predict
inequities in early childhood sleep health. We propose testing 3 specific and 1 exploratory aims: (1) Evaluate
the effect of understudied risk factors (racism, housing insecurity, screen media use, toxic stress) on child
sleep health; (2) Evaluate the effect of socio-cultural and neighborhood factors on (a) family factors and (b)
children's sleeping environment factors; (3) Define the relationship between multilevel ecologies (socio-cultural
and neighborhood, family, child sleeping environment) and children's sleep health; and (4) (Exploratory)
Explore child stress as a mediator or moderator of multilevel ecologies on child sleep health. Our central
hypothesis is that socio-cultural and neighborhood risk factors increase family risk factors, negatively impacting
the child's sleeping environment and consequently predicting worse sleep health. We will test these aims and
central hypothesis in a micro longitudinal study (three time points over six months) of 550 racially and
economically diverse families of young children (20-48 months of age, when sleep health disparities likely
develop) in two geographic sites of the Midwest with rigorous multi-level measures (e.g., Geographic
Information Systems [GIS], self-report, ecological momentary assessment [EMA], actigraphy, and physiological
biomarkers) using structural equation mediation modeling. The project will provide a critical next step to reduce
disparities in young child sleep health problems and their downstream effects. It will also provide the
opportunity for an early-stage investigator to change research directions. The proposal aligns with NHLBI's
strategic plan to identify factors accounting for differences in population health and individual biology.

Public health relevance
PROJECT NARRATIVE Sleep health is essential for well-being, yet significant disparities exist for young children (2-5 years old) who are racially minoritized or living in poverty. The objective of this research is to define disparities in early sleep health by examining how socio-cultural, neighborhood, and family risk factors predict conditions in children's sleeping environment and sleep health. This study will provide a critical next step in reducing disparities in early childhood sleep health and its downstream effects.